THE ROLE OF PTEN IN MICROGLIAL PATHOBIOLOGY AFTER EXPOSURE TO REPETITIVE MILD TBI

Repetitive mild traumatic brain injury (r-mTBI) is one of the strongest risk factors for developing
neurodegenerative diseases. To date, no disease modifying therapies have been developed to prevent the long-
term consequences of TBI. There is a need to advance our current understanding of the cellular mechanisms
driving the long-term neurological deficits after TBI, as this could lead to the identification of novel therapeutic
targets. Neuroinflammation mediated by resident microglia is a common feature of human and animal models
of TBI. Factors governing the propagation and persistence of disease associated microglial responses in the
chronic sequelae of TBI remain elusive. We have established a mouse model of r-mTBI that recapitulates many
features of human TBI and thus represents a translationally relevant preclinical platform. From this model we
have generated a molecular library of microglia gene profiles, at a range of timepoints post-injury that provides
a unique and detailed time-course of the microglial neuroinflammatory response to r-mTBI. Particularly, we
reveal deficits in energy bioenergetics, cytokine signaling, lipid metabolism, and a pro-inflammatory signature
of microglia at chronic timepoints, which appear to be driven by the activation of Phosphatase and Tensin
Homolog (PTEN) signaling. PTEN is a lipid phosphatase that antagonizes phosphatidylinositol 3-Kinase
signaling, a critical node vital for regulating cell survival, energy bioenergetics, autophagy and inflammation.
PTEN is highly expressed in myeloid cells, and its dysregulation can trigger the activation of inflammatory
responses. Multiple cell types express PTEN, thus PTEN inhibitors lack the specificity needed to target PTEN
signaling in microglia. In a pilot study, we have shown that PTEN deletion in myeloid cells after 1 mo
dampens disease associated microglial responses and proinflammatory signature in our model. In this
new application, we plan to extend these studies to further clarify the role of PTEN in regulating microglia
responses in the context of TBI and demonstrate whether microglia specific PTEN deletion can mitigate TBI
mediated neuroinflammation/neurodegeneration and chronic functional outcomes. We will compare TBI-
dependent responses in the presence or absence of PTEN deletion to reveal microglial specific targets that
correlate with favorable outcomes after r-mTBI and represent novel therapeutic targets. We will achieve this by
utilizing a tamoxifen inducible mouse model that will specifically target PTEN deletion in microglia and not
other myeloid cells (Hexbcre+/PTENfl/fl). We will induce PTEN deletion using three therapeutic time-windows
(i.e., pre-injury, early and delayed), and examine functional and pathobiological outcomes, scRNAseq profiles
and functional activities of microglia at 6 mo post-injury. Our goal is to clarify the role of PTEN as a negative
regulator of microglial pathobiology in the chronic sequelae of r-mTBI, and to identify unique gene signatures
and reparative mechanisms in microglia induced by PTEN deletion that can be explored as novel microglial
specific targets in TBI and other neurodegenerative diseases where neuroinflammation is a critical contributor.

Public health relevance
Repetitive mild traumatic brain injury (r-mTBI) can induce long-term neurological damage, and disease associated microglial (DAM) mediated neuroinflammation is a common feature of TBI, which our data shows to be driven by the overactivation of PTEN signaling. In this study, we will clarify this role of microglial specific PTEN as a novel target for ameliorating TBI mediated microglial pathobiology and neurodegeneration, utilizing a tamoxifen inducible mouse model (Hexbcre+/PTENfl/fl) that specifically deletes PTEN in microglial cells alone. From this study, we aim to identify unique microglial specific gene signatures and reparative mechanisms induced by PTEN deletion that can be explored as novel microglial specific (and disease modifying) therapeutic targets in TBI and related neurodegenerative diseases where DAM mediated neuroinflammation plays an important role.